The Colorado Building Interdisciplinary Research Careers in Women's Health Program

Project Summary
This application is for the 4th cycle of funding for the Colorado Building Interdisciplinary Research Careers in
Women’s Health Research (BIRCWH) K12 program, established in 2007. Over the past 15 years, we have had
21 Scholars in the program, 18 of whom have remained in academic medicine and are funded. Collectively,
these Scholars have published over 550 publications since their time in the BIRCWH program (not including
abstracts). For our proposed 4th cycle, we will continue to work with our Scholars and their carefully chosen
primary mentors in the rich academic environment of the University of Colorado-Anschutz Medical Campus.
We will help them form innovative interdisciplinary Scientific Advisory Committees (SACs). Scholars and their
entire SACs as well as BIRCWH leadership will meet twice yearly and participate in monthly trainings using an
evidence-based curriculum focused on developing academic and career development skills. In addition,
learning from our experience in 3 prior cycles of BIRCWH and in addition to our successful ongoing methods,
we propose several key program innovations:
o The evidence-based curriculum now will also include focus on how to integrate sex and gender into all
steps of research from study design to analysis.
o Encouraging Scholars to begin working on their individual K award relatively early in the course of
their tenure as a BIRCWH Scholar (i.e., 8-9 months after initial BIRCWH Scholar appointment) with strong
mentor/SAC/BIRCWH leadership support.
o Ongoing interaction for BIRCWH Scholars with their SACs following completion of the BIRCWH Scholar
period (through the next academic steps) to extend guidance while also working to establish independence.
o Addition of bioinformatics as a cutting edge, cross-cutting tool that will serve to interweave our foci.
o Increased biostatistician availability to meet the complex statistical needs of the Scholars.
o Addition of a BIRCWH facilitator, Dr. Laura Brown, a successful former BIRCWH Scholar, who will work
with Scholars by focusing on research and career development issues including helping them work on their
next grants- grants that will help them transition successfully to their post-BIRCWH careers.
o A strong focus on working to increase diversity of our BIRCWH Scholars.
Our overall goal is to: Support top applicants from a diverse pool of exceptionally motivated and talented
individuals, and provide them with an appropriately tailored, top-quality interdisciplinary mentored research and
career development experience. The excellent institutional support for the Colorado BIRCWH, with strong
focus on women’s health, will also fuel the growth of this important program which aims to develop successful,
independent interdisciplinary scientists in women’s health and sex differences research and thereby improve
the health of women.

Public health relevance
Project Narrative The areas of women’s health and sex differences research have long had an inadequate cadre of investigators with top quality training sufficient to make them competitive for limited research funding dollars. By using interdisciplinary training and excellent mentoring to develop the careers of the research leaders of tomorrow, we can address the most important, pressing questions in women's health and sex and gender differences. By equipping early career scientists to find the answers, we have every expectation that this grant will lead the way to tangible improvements in women's health in the United States.